Arizona Surveillance and Research Center for Developmental Disabilities

DESCRIPTION: SB is a monitored condition in birth defects surveillance networks across the U.S. and in most developed countries. A public health emphasis on prevention, early identification, and multidisciplinary treatment has been associated with a decreased prevalence and improved outcomes in individuals with SB in the US. Despite the decline in SB births since the implementation of folic acid fortification of cereals and wheat grains in the US, there are still substantial numbers of SB births that occur each year. Although much is known about the management of SB and the multiple co-morbid conditions and complications that occur in affected individuals, there are few systematic, longitudinal studies on population-based cohorts of children or adults. In 2003, the Centers for Disease Control and Prevention (CDC), the Agency for Healthcare Research and Quality, and the Spina Bifida Association of America hosted a multidisciplinary meeting to review the available research on conditions impacting the lives of individuals with SB and to develop a national research agenda. The purpose of this agenda was to identify research priorities in 16 of the most important co-occurring conditions in SB and advance research efforts to improve the quality of life of those affected, as well as to guide policy makers, educators, clinicians, and caregivers in the development of practice parameters, public policy, and public health activities that address the needs of this population. The hypothesis guiding this research is that population-based surveillance and integrated research programs are effective in determining the prevalence of disorders and establishing data on health outcomes and the types of care for these disorders. Such population-based surveillance for individual disorders is an important first step to understanding the full range of clinical outcomes for affected people. The availability of longitudinal data on these cohorts provides an opportunity to document and assess the natural history of the condition and the effects of various diagnosis and treatment strategies. The project proposes that Arizona contribute population-based data on 3-5 year old children with SB to achieve the following specific aims: Specific Aim 1: Generate a population-based dataset that can describe the natural history of SB, co-morbid conditions, and related complications as baseline data in a longitudinal cohort; Specific Aim 2: Describe the medical and social services received by individuals with SB and their families, including knowledge of prevention, and whether these vary by race/ethnicity and socioeconomic status. These specific aims will be achieved through completion of the following research objectives: 1. In collaboration with CDC, refine and finalize the protocol for population-based surveillance and long-term follow up of individuals with SB, building on the results of a CDC-funded pilot project currently underway.2. Identify a sample of children affected by SB using state based Birth Defects Surveillance Systems.3. Recruit children and their families for participation in the study.4. Gather data and information using a combination of methods, including interviews, survey, records abstraction, and neuropsychological testing.5. Assess the effectiveness of data collection methods.6. Assess the outcomes of the project.

Public health relevance
3. Research Strategy A. Background and Significance Spina bifida is a neural tube defect (NTD) that occurs in the first month (21-28 days) after conception and is usually associated with an open defect containing the spinal cord2,3,4. Spina bifida shows variable severity, with the mildest form being spina bifida occulta and more severe forms involving a large open lesion, with involvement of the spinal cord and associated neurological deficits.5 Neural tube defects, including spina bifida, are the second most common major malformation in newborns, occurring in approximately 1 in 1,200 live births. Hispanic infants are at increased risk of spina bifida, followed by Caucasian infants.6,7,8,9 The prevalence of NTD-affected pregnancies has been higher among Hispanic women than in women in other racial/ethnic populations both before and after folic acid fortification.10,11 Spina Bifida, Related Complications, and Co-Morbid Conditions Individuals with spina bifida have complicated medical needs beginning at birth and lasting throughout life. Neurosurgical treatment at birth includes closure of the spinal defect, and frequently placement of a ventriculoperitoneal shunt to prevent complications of hydrocephalus that result from an associated Chiari II malformation. Spinal cord involvement produces paralysis below the level of the lesion, neurogenic bladder and bowel, and decreased circulation to the skin. Orthopedic complications such as scoliosis, and genitourinary complications such as recurrent infection and progressive renal disease are also encountered frequently.5,12 Higher level cord lesions (high lumbar and thoracic) are associated with more complicated medical needs13,14 and use of a wheelchair for mobility. The medical, educational, psychological, emotional and social challenges of affected individuals are many, and they often vary across the life cycle. Childhood Children with spina bifida are at risk for many complications after birth including hydrocephalus, Chiari crisis and shunt complications, infections or malfunction.15 Shunt complications are associated with additional physical effects, and unrecognized Chiari changes may cause significant cognitive and motor deficits.16 Bowel and bladder management is a primary focus of medical intervention in the preschool years, both to promote social integration in the classroom and to protect skin from breakdown. Children typically receive early intervention services to promote motor development. When children with spina bifida enter the school system, they usually receive educational assistance through an Individualized Education Plan (IEP) or 504 Plan. Because many children with spina bifida have academic difficulties, recognition and management of learning disabilities in the school system is imperative to support educational progress. Participation in regular physical activity is encouraged to avoid obesity due to decreased mobility. Adolescence Adolescents with spina bifida face the challenge of transitioning to adult medical and vocational systems, often with decreased community assistance and increased needs for personal independence. Bowel and bladder incontinence may be ongoing issues that lead to medical complications and limit social integration into teen society. The adolescent with spina bifida frequently desires increased independence, but outlets for this independence, such as driving, are limited by physical concerns; and, vehicle adaptations are costly and are not available in many communities17. Similarly, teens with spina bifida have an interest in sexual relationships, but complex medical issues and difficulty meeting and engaging with teen peers frequently limit success in these relationships18. Several investigations of mental health in individuals with spina bifida have found an increased incidence of depression.19,20 Adolescents frequently receive educational assistance for learning disabilities. As they begin to transition to independent job acquisition, executive function impairments may make employment difficult to attain and maintain. Adolescents with significant cognitive impairments may also require support to manage legal and medical issues. Adults Adults with spina bifida face all of the medical complications of spina bifida seen in younger individuals. In addition, they must manage medical issues of typical aging. Skin breakdown in thinner, more fragile adult skin puts adults at even higher risk of skin ulceration and underlying bony infection than younger individuals. Cognitive impairments including learning disability, executive functioning impairments and intellectual disability may make independence and the ability to access medical care challenging21. Many adults with spina bifida will not qualify for significant medical or vocational assistance due to relative sparing of language skills that limits their ability to qualify for services provided to individuals with intellectual disability. Folic Acid Supplementation A public health focus on folic acid supplementation began in the US in 1992 when the U.S. Public Health Service recommended that all women of childbearing age consume 400μg of folic acid daily to help prevent NTDs in their offspring.22 In 1998 cereal grain products were fortified with folic acid.23 Over the next 2 decades the rates of spina bifida and anencephaly in the U.S. declined in the approximately 30% in the post-fortification period.24 Changes in the incidence of spina bifida in the post-fortification period were not significant, but ongoing ethnic disparities persist with higher rates of spina bifida in the Hispanic population..9 Prevalence of Spina Bifida in Hispanics and Native Americans The prevalence of spina bifida live births in Hispanics and Native Americans is significantly higher than in whites and other non-Hispanic groups.25,26,27,28 Rates declined significantly during the first post-fortification years, but have since hit a plateau. Previous research has examined genetic contributing factors, with mixed results. More investigation is needed to definitively identify genetic influences in individuals with spina bifida, especially those genetic influences associated with ethnicity/race or gene-gene and gene-environment interactions.29 While the reasons for the disparity in rates of spina bifida between Hispanics and others is unknown, there are several studies that point to cultural and socioeconomic issues as contributory.30 The levels of education, income, and acculturation are factors known to influence the risk for spina bifida. Of special interest is the finding that US-born Hispanics are not at increased risk when compared to whites, but those who are foreign-born and recently acculturated (less than five years in the US) are at an increased risk.31,32,33 This finding points to environmental factors rather than genetic factors as the cause for this particular discrepancy. Lack of knowledge on maintaining folate status during pregnancy, exposure to different processed foods, or not including fortified foods in the traditional diet may be contributing to this increase. Corn-meal products were not included in the original fortification regulations, and while US-produced corn meal products are fortified, many imported products are not. In 2006, the largest Mexican exporter of corn-meal products to the US collaborated with the Spina Bifida Association, Walmart, and the National Council of La Raza to determine the best methods for fortification of their products to meet FDA standards. As of the end of 2008, there was no documentation that this had occurred. Some researchers proposed that this was a primary cause for elevated rates of spina bifida in Hispanics.34 While there is limited published literature on Native Americans and spina bifida, it is possible that the use of non-fortified products may contribute to the higher rates of spina bifida births in that population as well. If some of the spina bifida births in these high-risk populations are preventable, then increased efforts need to be made to address the problem. Currently, there is no direct evidence to show that cultural barriers are in fact contributing to the increased rates through a knowledge gap, dietary issues, or other socioeconomic factors. This project will attempt to provide information to identify contributing factors and proposed solutions to target these concerns. Project Relevance to the field The project will collect prospective data on a cohort of children with spina bifida. The data will document medical treatments and complications as they occur, potentially identifying precursors or contributing factors. Elimination of avoidable risks and complications in these children will improve their quality of life and prevent other more serious complications that lead to additional functional and intellectual impairments. As with many other developmental disabilities, children with spina bifida are living into late adulthood due to advances in treatment and the improved level of medical care provided to them. Along with this prolonged life comes the risk of additional complications and comorbid conditions that are new to these individuals or will become exacerbated with age. To ensure that these individuals not only have a prolonged life but one with a high level of quality, efforts need to be made to diagnose and treat some of these conditions as they arise or prevent them from occurring at all. This project proposes to initiate a population-based, prospective longitudinal study of children born with spina bifida to document the natural history of the disease and the variability of progression, complications, and comorbid conditions among different members of the cohort. Since the project is intended to be population-based, it is imperative that all population groups are represented. The state of Arizona has a Hispanic population which is double that of the average US Hispanic population, as well as a Native American population four times higher than the national average. The Hispanic population in Arizona consists of both US-born and foreign- born Hispanics. Given that these two populations seem to be at increased risk for spina bifida, the Arizona population is an ideal group for study of this problem. Furthermore, the Arizona system is constituted in such a way that the majority of children with spina bifida are cared for at either one of two clinics in the state, providing ease of access for enrollment. Lastly, the Arizona Birth Defects Monitoring Program (ABDMP) has instituted a rapid response system of identification and clinical referral for all newborns with spina bifida. The system identifies children within the first 6 months of life so that timely care can be established and patients can access the full range of diagnosis, treatment and prevention programs. The current processes and protocols in place in Arizona, its demographic make-up, and the long standing collaboration between the sites involved in this proposal will help to assure the success of the project. B. Previous Research Experience The Arizona University Center on Disabilities (AzUCD) program site at the University of Arizona (UA) and the collaborators on this project have extensive research experience in birth defects and developmental disabilities surveillance, case finding, longitudinal data collection, case confirmation, interview development and conduct, program evaluation, qualitative and quantitative analysis methods and manuscript development. Investigators also bring clinical experience and expertise in developmental disabilities, especially the care of individuals with spina bifida. Surveillance The AzUCD at the UA and its staff have designed and implemented surveillance systems for the collection, management, analysis, evaluation, and reporting of developmental disabilities for over a decade. Population-based surveillance programs carried out by AzUCD include Centers for Disease Control and Prevention (CDC)-funded projects for Fetal Alcohol Syndrome (FAS) from 1997 to 2003 and again in 2009; Autism Spectrum Disorders (ASD) from 2000 to present, and Duchenne and Becker Muscular Dystrophy (DBMD) from 2002 to present. This experience provides us with the necessary knowledge and skills to obtain and organize available data, to create analytic datasets, examine data trends and to disseminate information on trends in health care for these populations. These projects draw extensively on relationships that have been created with Arizona research partners such as the Arizona Department of Health Services (ADHS), Arizona Department of Education, pediatric inpatient units and outpatient clinics, and the Arizona Children's Rehabilitative Services (CRS) program, which funds regional multidisciplinary clinics for children with special health care needs. Longitudinal Data Collection The core research team has experience in collecting longitudinal data for both consented and surveillance studies. Our DBMD surveillance program involves retrospective data collection, including follow-up and record searches for all cases in the database. Their activities throughout their lifetime are collected in the database, and each case is followed at multiple sources. The DBMD program also collects data directly from the families through computer assisted telephone interviews and self-report questionnaires. Each family is followed and contacted from year to year, obtaining additional data to supplement the baseline information, as well as questionnaires on different topics of interest. We are now in the fourth year of data collection for the interview portion of the project. The AzUCD core team has provided participant tracking, randomization, data collection, and data analysis services to the Department of Pediatrics for a variety of research projects under a Complementary and Alternative Medicine (CAM) Center award. The activity continued for six years, and five independent research projects were carried out, including projects focused on cerebral palsy, recurrent abdominal pain, and asthma. Each of the projects required high levels of participation from families and their children, including daily reports, weekly to twice-weekly appointments with practitioners, and multiple 1-2 hour long assessments to document change. The AzUCD core team developed randomization schemes, participant tracking protocols, data collection timelines, participant follow-up, data entry, data cleaning and analysis. These projects required intensive follow-up to ensure families complied with study protocols and completed all elements of the data collection. Publications from the CAM Center projects are included in the appendix. Investigators Christopher Cunniff, MD is Professor of Pediatrics and the Chief of the Section of Medical and Molecular Genetics (MMG), Department of Pediatrics, University of Arizona College of Medicine. He will serve as Co-PI with Dr. Sydney Rice (see below). Dr. Cunniff has extensive experience in the evaluation and treatment of children with birth defects, developmental disabilities, and genetic disorders. He directs the clinical genetics activities of MMG. Dr. Cunniff also has considerable knowledge, experience, and a record of publication on the epidemiology and surveillance of birth defects and developmental disabilities. Dr. Cunniff was PI of the CDC-funded Arizona surveillance program for Fetal Alcohol Syndrome from 1997-2003 as a member of the FAS Surveillance Network (FASSNet), and he currently serves as PI on a FAS Surveillance cooperative agreement with the CDC. He also serves as Co-PI of the Arizona Developmental Disabilities Surveillance Program for monitoring of Autism Spectrum Disorders and Intellectual Disabilities, and as the PI of the Arizona Muscular Dystrophy Surveillance Tracking and Research Network under cooperative agreements from the CDC. Sydney Rice, MD, MS is Assistant Professor in the Section of General Pediatrics in the Department of Pediatrics at the University of Arizona. She is a board certified developmental pediatrician and has worked extensively with children with special health care needs. She will serve as Co-PI with Dr. Cunniff. Dr. Rice has served as a general pediatrician, initially at a community health center on the Arizona-Mexico border for 4 years, serving an underserved Hispanic population of children, and later as a primary care physician for children with special health care needs at Children's Clinics for Rehabilitative Services, a multi-specialty, interdisciplinary clinic serving children with special needs in southern Arizona. After working at Children's Clinics for Rehabilitative Services (CCRS),she completed a developmental- behavioral pediatric fellowship and Masters in Health Evaluation Sciences at the University of Virginia. After fellowship training, she was appointed Assistant Professor at the University of Virginia and served as the Medical Director of the University of Virginia (UVA) Kluge Children's Rehabilitation Center. She participated in studies at UVA that examined outcomes from therapy and pharmacologic interventions in children with a variety of neurodevelopmental disabilities. Dr. Rice now serves as Medical Director of CCRS, which serves the southern region of Arizona. She participates in two interdisciplinary spina bifida teams, one serving children with spina bifida and the other serving teens and young adults. She serves as the Primary Investigator (PI) of the UA Program Site of the AzUCD. Dr. Rice is bilingual in English and Spanish and has used her Spanish skills in past and current clinical settings. All of Dr. Rice's job positions have been devoted primarily to the care of medically underserved populations. As a developmental and behavioral pediatrician, Dr. Rice has extensive clinical experience with children with spina bifida. Her Masters degree in health evaluation sciences has provided her with the necessary training, tools, and knowledge to conduct research projects, prepare grants and reports, and interpret data analysis results. Her research areas of emphasis are on spina bifida and autism spectrum disorders. Dr. Cunniff has extensive experience in surveillance projects and has a thorough understanding of human subjects issues, medical records abstraction, survey administration, and other forms of data collection. Dr. Rice will focus on clinic related data collection, instituting protocols, and assisting the program coordinator in obtaining the data elements necessary. Dr. Cunniff will have primary responsibility for activities related to the planning and execution of data collection, staff management, human subjects approval, and reporting. Sydney Pettygrove, Ph.D., will serve as project Epidemiologist. She is an Assistant Professor in the College of Public Health and an epidemiologist with expertise in the surveillance and epidemiology of birth defects and developmental disabilities and in environmental epidemiology. She completed a dissertation on neural tube defects for the PhD program and Johns Hopkins University entitled "A case-control study of neural tube defects and agricultural chemicals using geographic information systems". She serves as Co-Principal Investigator on the autism spectrum disorders and mental retardation population surveillance grant. Dr. Pettygrove is currently the epidemiologist for the Arizona Developmental Disabilities Surveillance Program and the Arizona Muscular Dystrophy Surveillance and Research Program. C. Methodology The methodology for accomplishing the 8 research objectives listed in the specific aims section of this document will be achieved through the following activities: protocol development, case- finding, data collection, program evaluation, and additional research questions. Each of these activities is defined including the approach, significance, and innovation in detail below. The specific aim and research objectives addressed are also listed. Protocol Development Protocol development activities contribute to the following specific aims: Specific Aim 1: Generate a population-based dataset that can describe the natural history of spina bifida, comorbid conditions, and related complications as baseline data in a longitudinal cohort; Specific Aim 2: Describe the medical and social services received by individuals with spina bifida and their families, including knowledge of prevention, and whether these vary by race/ethnicity and socioeconomic status. Protocol development involves activities for the achievement of the following research objective: 1. In collaboration with CDC, refine and finalize the protocol for population based surveillance and long term follow up of individuals with spina bifida, building on the results of a CDC funded pilot project currently underway. Approach Variations occur in the uptake of hospital and patient care for progressive conditions, especially at younger ages. Reasons for this variation are multifaceted and most likely include factors such as service availability, the appropriateness of services according to age group, and a complicated mix of psychosocial factors, including individual and family perceptions of health care and the interpretation of its benefit. With this in mind, we propose to collaborate with the CDC and other awardees through the development of a coordinating committee that will address these issues through conference calls and face-to-face meetings to finalize the protocol for use in the current study. The CDC has already piloted the tools and variables to be used in this study, therefore the first 6 months of this study should involve ensuring the reliability and applicability of the variables in the existing dataset. The 16 research priority areas identified in the research agenda created through the "Evidence-Based Practice in Spina Bifida Developing a Research Agenda" meeting in 2003 will be drafted into data analysis plans. The data analysis plan is a brief, 3-page summary detailing the purpose of the research question, what variables are needed to conduct the analysis, the sample size necessary and detailed descriptions of the statistical analyses to be used to complete the research. Each of these research plans can be compared to the existing dataset to determine if: 1) the data as collected are adequate for analysis; 2) necessary variables are missing or incomplete in the dataset; 3) any other variables or methods for collection are needed to address the research question adequately. Collaborative approval of the data analysis plans should be voted on by members of the coordinating committee. Any changes to the data collection protocols and instruments will be guided by the findings of the preliminary evaluation of the data analysis plans. Approved plans will be incorporated into the finalized research protocol and submitted to each site's institutional review board for approval. A primary goal of this project, as with other surveillance systems, is to classify systematically every patient identified through established case-finding procedures. Elements of the case definition are critical for inclusion in the electronic abstraction instrument, and the appropriate application of these elements from each submitted patient abstraction ensures consistency and validity throughout. The coordinating committee will need to review and revise, if necessary, the case definitions implemented during the pilot phase of this project. Innovation Many surveillance programs go through numerous iterations and revisions of the data collection instrument due to the inadequacy of the variables collected for actual use in statistical analysis intended to address major research questions. Intensive, up-front assessment of the availability, viability, and necessity of each variable being collected can eliminate future efforts to retrospectively the information essential to the success of an analysis. We feel it is imperative to allot adequate time to this essential step in the process prior to the engagement of data collection staff and the conduct of other operational activities. Flawed research questions and data collection instruments create extensive work at the back-end costing time and resources both of which are limited in this brief two-year project. Proactively addressing these issues early on will increase the success and impact of this project in the long run. Each of our surveillance projects has operated as a collaboration between grantees and the CDC with each PI and the CDC representative comprising a coordinating committee in addition to subcommittees for the various objectives of the project. The coordinating committee will need to decide on a common timeline, determine the feasibility of the proposed CDC protocol and institute benchmarks to assess the success of the project activities at various time points along the way. One of the primary objectives for the coordinating committee will be making decisions about changes when the protocol does not address issues that come up in the field. With our experience on numerous projects developed by committee, the AzUCD can circumvent many of the problems or limitations with the protocol through the work of the coordinating committee. Significance Although a great deal is known about the prevalence of spina bifida, there are currently no population-based studies of detailed clinical outcomes in a large cohort of affected persons. Such studies are important for a number of reasons: (1) a population-based sample is most representative of the total population of affected individuals and tends to minimize problems such as referral bias; (2) the full range of phenotypic abnormalities is present in a population- based cohort and can be correlated with the phenotypic information that is collected from multiple sources; (3) within homogeneous subgroups, clinical outcomes can be correlated with specific treatment regimens provided at specific treatment settings; (4) clinical interventions and their health outcomes can be measured on a population basis to help describe the type and prevalence of secondary conditions and complications occurring among individuals with spina bifida. Timeline The first three months of our timeline involves collaborative drafting of all major research questions into data analysis. By the end of the sixth month, we are proposing to have all elements of the protocol, data collection tools, and ancillary documents complete and ready for submission to the various human subjects protection programs. If the protocol involves minimal risk, then the typical turnaround in Arizona is 6-8 weeks. Case Finding Case finding activities contribute to the following specific aim: Specific Aim 1: Generate a population-based dataset that can describe the natural history of spina bifida, comorbid conditions, and related complications as baseline data in a longitudinal cohort; Case-Finding involves activities for the achievement of the following research objectives: 2. Identify a sample of children affected by spina bifida using state based Birth Defects Surveillance Systems. 3. Recruit children and their families for participation in the study. Access to families Arizona rates of spina bifida from 1998 - 2003 show approximately 4.16 per 10,000 live births, which demonstrated a 16% reduction from pre-folic acid fortification years as compared with a 34% reduction on a national level.35 The birth rate is higher than the reported national birth rate of 3.47 per 10,000 live births. This discrepancy could be attributable to Arizona's high Hispanic population (29.2%) which is almost double the national population average (15%) and will represent the fifth-ranked state for gains in the Hispanic population through the year 2025 with 48% of Arizona immigrants coming from Mexico.36 Research has shown that birth prevalence of spina bifida in the Hispanic population is 30% higher than for white infants.9 Arizona ranks sixth among all states for its Native American population and while these data are not reported at a national level, in Arizona the rate of spina bifida for Native Americans is significantly higher than whites.37 Birth rates for Arizona populations are shown in Table 1. Table 1. Rate of Spina Bifida by Race Ethnicity from 1999-2004 per 10,000 births.6,39 Ethnicity/Race Arizona (US) Race Arizona (US) Hispanic 4.97 (4.17) White 3.10 (3.25) Native American 5.13 (------) Black 1.60 (2.95) Arizona Birth Defects Monitoring Program (ABDMP) The ABDMP is a population-based surveillance program which provides information on the occurrence of 44 categories of birth defects. These specific birth defects are monitored at the recommendation of the National Birth Defects Prevention Network and Centers for Disease Control and Prevention. They were selected because of a combination of factors: they require medical or surgical intervention, they considerably affect the child's appearance, they seriously affect the health and development of the child, they have a significant public health impact, their frequency of occurrence, and/or the level of existing knowledge on their etiology and risk factors.38 The ABDMP provides ongoing surveillance to monitor trends in the occurrence of these birth defects and detect the onset of possible problems.39,40,41 The information is used to plan and evaluate birth defect prevention efforts and to direct allocation of resources for health services. Such a registry is necessary because other systems for reporting birth defects, such as birth certificates and hospital discharge data, tend to be inaccurate or incomplete due to under-reporting of cases, lack of specificity of the type of birth defect, and/or incomplete demographic data.42 To provide accurate and current information for health planning and prevention activities, the ABDMP in 2003 entered into a five-year Cooperative Agreement with the Centers for Disease Control and Prevention to develop a rapid reporting system (RRS) for birth defects. The goal of the RRS is to identify infants born in Arizona with anencephaly, encephalocele, spina bifida, cleft lip, or cleft palate within six months of birth and to provide families of living children with information and resources for follow-up medical and social services. In this way the ABDMP hoped to increase the percentage of children with these birth defects who receive coordinated, multi-disciplinary follow-up services to minimize the long-term disabilities associated with their condition. It was also expected that this program would increase the number of families of children with birth defects receiving support from other families of children with similar difficulties. Furthermore, this rapid-surveillance system would enable the Arizona Department of Health Services Folate Committee to track trends in NTD) occurrence and evaluate the efficacy of programs educating the public on folic acid for NTD prevention. The ABDMP is the State- level birth defects surveillance system where spina bifida cases have been identified and verified. The Arizona Birth Defects Monitoring Program (ABDMP) will be funded for 2010-2014 and has set a high priority on accurately and completely registering all Arizona-born cases of spina bidifa. This statewide, population-based registry has a long-term, working relationship with the UA Dept of Pediatrics. The ABDMP has committed to query the state birth defects registry for liveborn, non deceased cases of spina bifida that are found in the state birth defects registry (see attached letter of support). Preliminary assessment run in February 2010 shows a case count of "spina bifida without anencephaly" for children that currently would be 3-5 years old, of 144 cases from 2004 - 2008. Data for the birth years 2004-2007 are complete for cases registered by the ABDMP. The data for 2008 are still being collected. The few (8) cases...